Mechanisms of Prostate Cancer Metastasis

Contact PD/PI: Freeman, Michael R Project-004 (511)
ABSTRACT (PROJECT 4)
Aggressive prostate cancers (PC) exhibit phenotypic changes through a poorly-understood process termed
“lineage plasticity (LP).” LP typically occurs as a result of secondary resistance to androgen receptor signaling
inhibitor (ARSI) therapy and is identified by variant histology and emergence of stemness, neuroendocrine (NE)
and epithelial-mesenchymal transition features. LP can be a driver of genome and chromosome instability (CIN).
In the previous P01 cycle we were the first to report that the transcription factor ONECUT2 (OC2/HNF6β) is a
master regulator that specifies an NE transcriptional program in certain castration-resistant prostate cancers
(CRPC). OC2 suppresses androgen receptor (AR) target genes and acts as a survival factor. We developed a
novel class of small molecule OC2 inhibitors that inhibit growth and metastasis of AR-V7-positive mCRPC
xenografts. OC2 is thus a previously unknown driver of LP in aggressive PC that can be targeted with a drug-
like compound. Evidence from genetically engineered mouse models and tissue regeneration models
demonstrate that OC2 is upregulated under conditions that produce CIN. In the previous funding cycle we used
model systems, genomics data, and studies of human PC tissues and circulating tumor cells (CTCs) to assemble
evidence that CIN, OC2 activation, and nuclear shape instability (NSI) are shared features of both treatment-
naïve de novo metastatic PC and mCRPC. These findings suggest these are inherent to one or more aggressive
PC classes and may even occur in the absence of selection from ARSI. Using these observations as a scientific
premise, we hypothesize that OC2, CIN, and NSI act coordinately to drive LP and PC lethality. The Specific
Aims are: Aim 1. Determine the role of CIN in OC2-driven lineage plasticity. OC2 will be enforced in vivo in
human PC tissue regeneration assays to determine whether OC2 activity is dependent on CIN and whether OC2
promotes LP, CIN or NSI. Graft tissues from intact and castrated mice will be analyzed for CIN, LP, and NSI
using histologic, immunohistochemical, RNA expression profiling and bioinformatics methods. LP will be induced
in human mCRPC 2D and 3D human models by hypoxia and bone marrow stromal secretions to determine
whether these stimuli promote NSI and CIN. Aim 2. Identify mechanisms of NSI that promote lineage plasticity.
Tissue regeneration assays will be used to determine whether NSI induced by silencing the nuclear membrane
protein emerin (EMD) promotes CIN, LP, and OC2 activation. We will determine whether EMD silencing can
elicit or cooperate with CIN to drive tumor growth, LP and castration resistance. Aim 3. Investigate OC2
activation, CIN and NSI in parallel across primary and metastatic tumor cell populations. An established single
cell analysis approach will be used to determine whether CIN, NSI and OC2 activation co-exist in human PC
cells isolated from de novo metastatic and mCRPC cases.
Project Summary/Abstract Page 699
Contact PD/PI: Freeman, Michael R Project-004 (511)

Public health relevance
PROJECT NARRATIVE (PROJECT 4) The overall goal of Project 4 is to understand the relationship between expression and activation of the master regulator transcription factor ONECUT2 (OC2), lineage plasticity, chromosome instability and nuclear shape instability. We have found these to be shared features of both treatment-naïve de novo metastatic prostate cancer (PC) and metastatic castration-resistant PC, suggesting these properties are inherent to one or more subtypes of aggressive PC. We will use model systems, human data and tissues, and a range of molecular and computational approaches to identify new therapeutic approaches to lethal forms of PC. Project Narrative Page 700